Emerging Mycoestrogens: Impacts on Placental and Early Childhood Growth

PROJECT SUMMARY
The World Health Organization has called zearalenone (ZEN), commonly found in the food supply, one the
mycotoxins of greatest concern. Zeranol (ZER), a synthetic form of ZEN used to promote growth in livestock,
has been banned in the European Union because of established endocrine-disrupting properties. Both ZEN and
ZER bind to estrogen receptors α and β with higher affinity than other well-studied endocrine-disrupting
chemicals (EDCs), earning their designation as ‘mycoestrogens’. In utero exposure of animals to ZEN and ZER
disrupts offspring development, causing reduced fetal and birth weight. The impact of mycoestrogens on infant
health may start early, with altered development of the placenta. As the principal source of hormones and growth
factors for the growing fetus, the placenta is a sensitive target for disruption by environmental chemicals. Our
experimental data from a mouse model indicates reduction in placental weights and surface area along with
alteration of syncytialization pathways following ZEN exposure. Despite this compelling work in animal models
and evidence of widespread human exposure to these compounds, to date, no epidemiological research has
examined the impact of mycoestrogens on children’s health. The overarching hypothesis of the proposed
research is that mycoestrogen exposure in utero adversely affects placental development and impairs
fetal and infant growth. We will test our central hypothesis as part of the ongoing UPSIDE study, a U.S.-based
pregnancy cohort that investigates the role of the placenta in mediating relationships between prenatal
exposures and early development of children (n=326). We will quantify mycoestrogens in urine and placental
tissue across multiple time points (1st, 2nd and 3rd trimesters and birth). We will then examine maternal
mycoestrogen concentrations in relation to UPSIDE’s comprehensive placenta data, which includes: (1) basic
placental size characteristics (e.g. weight, surface area, thickness, volume, and diameter); (2) novel placental
endpoints (e.g. vascular surface area and number of vascular branch points) and (3) immunohistochemical
markers of trophoblast stress (e.g., apoptosis and cell proliferation).To study the impact of mycoestrogens on
perinatal growth we will compare novel mycoestrogen data to fetal biometry based on 2nd and 3rd trimester
ultrasounds as well as infant anthropometric collected longitudinally at birth, 1, 6,12, 24 and 36 months of age.
This will be the first epidemiological study to comprehensively assess maternal, fetal, and infant outcomes
following mycoestrogen exposure and will inform public health policy related to the increasing presence and
management of mycotoxins in the global food supply.

Public health relevance
PROJECT NARRATIVE Zearalenone and zeranol are chemicals made by fungus that are widely found in the food supply. In animal models, exposure to these chemicals alters pregnancy health with negative effects on offspring. This project will assess the potential harm of zearalenone and zeranol exposure in pregnant women and the impact of these chemicals on the placenta and fetal and infant growth. Our results in humans will inform public health policy on the increasing presence of fungus-related chemicals in the food supply.